Endothelial Cell Cycle State and Cell Fate

Establishing a functional vascular network is a rate-limiting step in embryonic development, the repair of
injured tissues, and the engineering of tissue replacements. Although we have made progress in identifying
factors that promote endothelial cell proliferation and sprouting, we lack understanding of how to properly control
endothelial cell growth and phenotypic specialization during vascular remodeling, which has created a significant
roadblock for clinical therapies, tissue engineering and regenerative medicine. Although multiple signaling
pathways have been implicated in the regulation of arterial-venous network formation, including flow-induced
mechanotransduction and Notch signaling, the mechanisms by which these signals coordinately regulate
endothelial cell growth suppression and identity were unclear. Our recent studies revealed that remodeling
vascular plexi are subject to systemic blood circulation, and that shear stress of different magnitudes promotes
differential growth responses and gene expression. That is, arterial/arteriolar shear stress levels promote Notch
signaling, and downstream p27-induced late G1 phase arrest that enables arterial gene expression (Fang 2017).
Conversely, flow magnitudes typical of veins/venules induce early G1 arrest, and enables upregulation of venous
genes. Interestingly, distinct endothelial cell cycle states appear to be maintained in arteries vs. veins postnatally.
We know very little about the role of cell cycle control in endothelial cell fate decisions, or the differential signaling
pathways induced by vessel-specific flow magnitudes, and how they may coordinately induce and maintain
endothelial cell cycle state and identity. The scientific premise of our research is that endothelial cell cycle
control is required for proper arterial and venous specification, such that when endothelial cells are in different
cell cycle states, they exhibit different propensity for arterial vs. venous gene expression. Support for this idea
comes from studies in embryonic stem cells that show cells in early vs. late G1 phase have a propensity for
mesoderm/endoderm vs. ectoderm fate, respectively (Paulkin 2014). Thus, our hypothesis is that differential
flow forces in arteries and veins induce different intracellular signaling pathways that promote distinct
endothelial cell cycle states, creating distinct windows of opportunity for the regulation of arterial vs.
venous gene expression. To ensure scientific rigor, we will test this hypothesis in vivo in models of arterial-
venous network formation and repair, and in vitro in human endothelial cell culture systems that allow flow
manipulation. We will define mechanisms by which vessel-specific flow magnitudes modulate endothelial cell
cycle state, determine how distinct endothelial cell cycle states enable differential phenotypic specialization
(artery vs. vein), and determine whether manipulation of endothelial cell cycle state can prevent or correct
arterial-venous malformations and enhance post-injury vascular repair. Evaluation of this hypothesis will yield
novel fundamental insights into blood vessel formation and regeneration that can be used to create human
microvasculature ex vivo and treat vascular pathologies.

Public health relevance
Project Narrative: We are studying the process of blood vessel formation and trying to understand how the growth of endothelial cells, that form the lining of blood vessels, is regulated by blood flow, and to what extent this is necessary in order to form a proper circulatory system. By defining factors that are needed for endothelial cell growth control and arterial-venous network development, we will gain insights needed to treat arterial-venous malformations, enhance neovascularization of injured tissues, and engineer circulatory networks from human stem cells that can be used for tissue engineering and regenerative medicine applications.